Uncovering sex-specific differences in ASH1L-disease

PROJECT SUMMARY
Autism spectrum disorder (ASD) affects 1 in 36 people and is a highly heterogeneous condition that has limited
therapeutic interventions and affects males more often than females. Similarly other disorders like Attention
deficit hyperactive (ADHD), Tourette syndrome (TS) and Schizophrenia (SCZ) have sex-specific differences in
their prevalence and clinical presentation. However, the precise cellular and molecular mechanisms that
underlie sex-specific dimorphisms associated these neuropsychiatric disorders are understudied. Our long-
term goal is to define the mechanisms that underlie sex-specific differences related to neuropsychiatric
disorders. Human genetics studies have identified high risk variants in genes that encode chromatin regulatory
factors associated with ASD, TS, ADHD, and SCZ. Our studies focus on the histone methyltransferase ASH1L
which has been identified as a gene of high importance that raises above genome wide significance in large
sequencing studies of ASD, TS and SCZ. We find that boys with mutations in ASH1L present more often with
ASD and ADHD, while girls with ASH1L mutations are more likely to present seizures. However, the molecular
mechanisms underlying sex-specific differences associated with deficits in ASH1L are unknown. We
developed a high-risk, high-reward research program that brings together in-depth clinical neuro-phenotyping
and stem cell pre-clinical studies to uncover mechanisms underlying sex-specific differences associated with
mutations in ASH1L. Our Central hypothesis is that ASH1L modulates transcriptional programs that govern
neuronal structure and function, and that sex-specific post-translational histone modifications lead to genome-
wide alteration of molecular programs that underlie male and female phenotypic differences in ASH1L related
disorders. We will test this hypothesis in the following specific aims:
Aim-1 will define the phenotypic diversity and severity of neurological presentations associated with ASH1L
disease with respect to sex-specific differences.
Aim 2 will define sex-specific cellular and molecular phenotypes caused by ASH1L dysregulation in human
neurons derived from male and female individuals with ASH1L mutations.
The impact of our work is that defining the clinical diversity and severity of ASH1L neurological phenotypes in
a male and female specific manner will be important for patients, families, and their physicians with respect to
medical treatment. Our work with patients, will allow us to uncover sex-specific differences clinically and
mechanistically using patient iPSC-derived neurons, which will allow us to identify targets for therapeutic
interventions. Finally, our work will also allow us to begin to prepare the ASH1L patient community for larger
scale clinical studies.

Public health relevance
NARRATIVE Mutations in the chromatin modifier ASH1L have been associated with autism spectrum disorders and epilepsy. ASH1L regulates large groups of genes simultaneously, including other genes that have been associated with autism and seizures such as FOXP1. We find that there are sex-specific differences in the presentation of the epilepsy and autism in patients with mutations in ASH1L. Our goals in this proposal are 1) clinically characterize patients with ASH1L mutations that variable degrees of phenotypic severity, and 2) identify the cellular defects and molecular signatures associated with ASH1L in stem cell experimental systems derived from a cohort of male and female patients with variable phenotypic severity.